Exosomes and Conventional Outflow Homeostasis

Project Summary
Glaucoma is an optic neuropathy in which the primary risk factor is elevated intraocular pressure (IOP).
Dysregulation of conventional outflow homeostasis results in elevated IOP. Key elements of outflow homeostasis
are the turnover of extracellular matrix (ECM), which also determines preferential flow passageways through the
tissue. In fact, there is recent evidence of differential ECM gene expression between regions of low and high
flow in the trabecular meshvvork (TM). In cancer, dysregulation of ECM homeostasis has been demonstrated to
involve extracellular nanovesicles, known as exosomes. Exosome release is tightly regulated, and they are
differentiated from other nanovesicles based on their size, cell type-specific function and cargo. Amongst others,
their functions include waste management, cell-cell signaling and ECM turnover. As a result, we hypothesize
that exosomes released from TM cells play a role in opsonizing ECM in the outflow pathway, contributing
to segmental flow, and altered ECM homeostasis in glaucoma. This study aims to investigate the role of
exosomes in regulating ECM by human TM cells and in TM tissues. During the independent phase, I will examine
how IOP effects exosome release and regulation in the conventional outflow pathway in terms of segmental flow.
Next, using human TM cells and TM tissues, I will investigate how exosomes can be used to ameliorate a
glaucoma phenotype and ocular hypertension. As outcomes of this research we expect to (i) identify a role for
exosomes in segmental flow (ii) determine the effect of IOP on exosome release and function (iii) identify ECM
targets for exosome regulation and, (iv) ascertain if exosomes can be used to normalize ECM homeostasis.

Public health relevance
Project Narrative Extracellular matrix homeostasis and its dysregulation that occurs in the trabecular meshvvork tissues of glaucomatous eyes is complicated, and an area of intense research. The role of actively released exosomes in these processes is largely unknown. Due to the natural flow patterns of aqueous humor through the trabecular meshwork tissues, exosomes represent ideal platforms to participate in conventional outflow regulation through the maintenance of extracellular matrix homeostasis.